DATA MANAGEMENT AND RESOURCE REPOSITORY FOR THE exRNA ATLAS PHASE II

Summary
Generation of high-volume sequence data has become a routine part of genome research, genetics and the
nascent field of precision medicine. With increasing interest in exRNA biology, the ability of researchers to
make discoveries and extract clinically relevant knowledge from these data requires access to new types of
tools and analytical approaches. However, the specialized tools and the expertise required for to develop and
implement effective solutions are beyond reach of most researchers. To address this problem, we have
assembled a team comprised of accomplished investigators to further host exRNA Portal resources and tools
for exRNA biology. Building on the success of ERCC Stage 1, we will explore novel mechanisms to collect,
identify, and characterize exRNA biotypes. Our team, in collaboration with Stage 2 investigators, will explore
the use of computational deconvolution to complement UG3/UH3 physical separation and isolation
methodologies to better characterize exRNA carriers and their cargo. By further extending our metadata
standards for Stage 1/Stage 2, exRNA Atlas will become a unique data repository utilizing the emerging
federated Data Commons based upon the principles of Findable, Accessible, Interoperable, and Reusable
(FAIR) data. ERCC data will be linked with geographically distributed resources, thereby contributing to a
continuous cycle of expanding knowledge and free flow of information. An agile DMRR governance structure
will ensure responsiveness to the input from all ERCC Stage 2 stakeholders and to the needs of the
community. Outreach and training will be targeted to various levels of expertise to ensure a lasting
engagement with a diverse community of users and contributors. By accomplishing these goals, DMRR will
empower researchers to make discoveries using exRNA datasets, and to extract from these datasets
actionable information and apply new knowledge to improve human health.

Public health relevance
Narrative Genome sequencing has become a routine part of genome research and is becoming used in the clinic to diagnose disease from blood samples. Building on the established Genboree platform, this project will support new technologies that will detect RNA molecules in human blood and other human biofluids for the purpose of diagnosing and monitoring diseases such as cancer.